Center for Integrated Multi-modal and Multi-scale Nucleome Research

The transcriptional regulatory sequences communicate with each other dynamically in the
3D nuclear space to direct cell type specific gene expression. Currently, a major barrier to
understanding the transcriptional regulatory programs is the lack of tools, models and maps
to explore the chromatin architecture in diverse cell types and physiological contexts. We
will address this pressing need by deploying transformative technologies to study the
chromatin architecture in mammalian cells at an unprecedented resolution and scale.
Specifically, we will generate navigable, cell-type-specific reference maps of chromatin
architecture in the mouse, macaque and human brains by integrating high resolution and
high throughput imaging and orthogonal single-cell-based genomic methods. We will also
dissect the role of chromatin architecture in gene regulation through a set of controlled
perturbation experiments in the mouse ES cells (ESC) and ESC-derived neural progenitor
cells (NPC). We will develop structural models of chromatin organization with advanced
polymer physics and statistical learning methods, and validate their predictive power in
embryonic stem cells and in ex vivo brain slices. Finally, we will make the reference maps,
analytical tools, visualization methods and structural models available to the broader
community. The proposed research project will dramatically transform our ability to analyze
the 4D Nucleome of complex tissues, and produce the much-needed maps, tools and
models for understanding the gene regulatory programs encoded in the linear genome
sequences.

Public health relevance
PROJECT NARRATIVE A major barrier to decoding the human genome is a lack of maps, models and tools to understand how transcriptional control sequences are spatially and temporally organized in the nucleus to regulate gene expression. The proposed research will address this pressing need by deploying transformative technologies to produce navigable reference maps and predictive structural models for diverse cell types in the mammalian brain. The results could facilitate the functional annotation of the human genome and improve our understanding of the genetic basis of a variety of neurological diseases.